LC/MS/MS validated method for quantitation of ergopeptines and -inines in grains and grasses

PROGRAM SUMMARY The current Official US Standards for Grains regulatory guidelines for ergot contamination in grains is a crude measurement and determines the percentage of ergot sclerotia in a sample, with ergoty grain defined as > 0.05% sclerotia in wheat, > 0.1% sclerotia in barley, oats, and triticale, and > 0.3% sclerotia in rye (CFR Title 7). The European Union Scientific Panel on Contaminants in the Food Chain concluded that a consistent relationship between the alkaloid concentration in the sclerotia and total ergot alkaloid concentration could not be established (EFSA 2005). No country has limits for individual ergot alkaloids in food or feed. Several recent factors have increased ergot invasion in crops, including no-till farming practices leaving the vegetation and ergot sclerotia on the soil surface for increased infection rates, the move to organic farming and avoiding fungicides, and the dramatic weather patterns with huge rainfalls that enhance increased Claviceps purpurea invasion of cereals and grasses in the spring/summer. No US veterinary diagnostic laboratory is providing a validated ergot alkaloid analysis of cereal grains and grasses by LC/MS/MS for the main Claviceps ergot alkaloids, the ergopeptines (- ines, biologically active) include ergotamine, ergosine, ergocristine, ergocryptine, and ergocornine, and their diastereomers the ergopeptinines (-inines, biologically inactive). In nature, ergopeptinines always accompany ergopeptines, and during storage of raw materials over time or improper storage, more ergopeptinines may form. The conversion of -ines to -inines can be rapid under certain laboratory conditions and -inines can be reactivated to -ines under certain conditions. Therefore, both epimers have to be determined for ergot alkaloid contamination of foods and feeds (Krska and Crews). This proposal is to develop and validate a sensitive LC/MS/MS method for ergpopeptines, ergotamine, ergosine, ergocristine, ergocryptine and ergocornine, and their -inines in cereal grains of wheat, barley, rye and grasses. The inclusion of a grass matrix for ergot alkaloid analysis by LC/MS/MS is not commonly addressed in any method but is extremely important for veterinary livestock exposures. The analytical range of detection chosen for the assay, 20 to 8000 ug/kg, represents veterinary toxicological important data for interpretation of animal feed and food contamination. RELEVANCE The LC/MS/MS analytical method for ergopeptines and ergopeptinines in small cereals and grasses will provide chemical analysis of potentially contaminated feed to be used for food animals or sold into the food chain. The current US Official Grain Standards of determining percentage contamination by ergot sclerotia in cereal grains is often inaccurate and ignores the great variation of alkaloid content in individual sclerotia. The increased use of no-till farming and leaving vegetation and sclerotia on the soil surface for the successive crops, consumer desire to utilize organic foods without chemicals, and dramatic weather events will tend to increase the incidence of Claviceps purpurea in cereal crops and grasses and exposure to ergot alkaloids.

Public health relevance
Narrative The goal is to develop and validate a sensitive assay for multiple ergot alkaloids, ergopeptines and their associated diastereomers the ergopeptinines, typically produced by Claviceps purpurea in multiple matrices of small grains and grasses. Currently, no veterinary diagnostic laboratory is analyzing grains and grasses by LC/MS/MS for ergopeptines and ergopeptinines. This research will 1) identify 10 ergot alkaloids, namely ergotamine, ergosine, ergocristine, ergocryptine, and ergocornine, and the corresponding -inine epimers by LC/MS/MS in several small grain matrices of wheat, barley, and rye with an expected recovery of 70 to 125%. 2) The research will develop a low detection limit of 20 ug/kg (ppb) and an upper detection limit of 8,000 ug/kg in the matrices, with evaluation of methods (such as dilution or smaller sample size) for sample ergot alkaloids exceeding 8,000 ug/kg. 3) The research will determine the best analytical approach using LC/MS/MS to determine ergot alkaloids in grasses, which represent an important animal exposure but challenge the diagnostician to acquire a ‘representative sample’ for analysis and interpretation and challenge the chemist to minimize matrix effects. 4) Compare analytical results for ergopeptines and ergopeptinines from this LC/MS/MS method in proficiency tests of cereal matrices when available.